Toll-like receptor control of endocytic antigen cross-presentation

PROPOSAL SUMMARY
There are critical vaccine barriers to eliciting cytotoxic CD8 T cells against intracellular pathogens. Current
vaccine technologies have yielded limited success for protection against infections with intracellular pathogens
like tuberculosis, malaria, and HIV where CD8 T cells prevent and control infection. Licensed vaccines generate
mostly neutralizing or opsonizing antibodies, and their efficacy is contingent on a stable antigenic profile. Some
adjuvants like alum elicit helper type 2 CD4 T cells, but CD8 T cell immunity has been difficult to achieve. CD8
T cells can target conserved internal microbial components that are more difficult for pathogens to mutate. The
unparalleled potency, cross-protective immunity, and immunological memory mediated by CD8 T cells
underscores the urgency of developing CD8 T cell vaccines. To elicit CD8 T cell immunity, an adjuvant needs to
induce MHC presentation of the antigens present in the vaccine formulation by dendritic cells (DC), potent
antigen-presenting cells that prime naïve CD8 T cells. The MHC class I presentation of exogenous antigens such
as vaccine components by DC takes place through cross-presentation. Understanding the mechanisms that
regulate DC cross-presentation is thus critical for designing adjuvants that elicit strong CD8 T cell immunity. Our
published and unpublished work has shown that Toll-like receptors (TLR), which detect microbes and alert the
immune system, positively regulate DC cross-presentation. When studying the regulation of cross-presentation,
it is important to consider the route of antigen internalization into DC. Depending on the size of the internalized
antigen, internalization can be through phagocytosis (for particles that are >1µm in diameter) or endocytosis
(<1µm in diameter). We found that the TLR-dependent regulation of cross-presentation is different for endocytic
and phagocytic antigens. The common component that dictates the efficiency of cross-presentation to CD8 T
cells is correct subcellular trafficking of MHC-I molecules to sites of internalized antigen. For phagocytic antigens,
TLR signals control the traffic of MHC-I molecules from endosomal recycling compartments (ERC) in DC
specifically to phagocytic antigens such as from bacteria or infected dying cells. For endocytic antigens, we found
that a distinct TLR signaling machinery is involved, which controls endocytic antigen cross-presentation to CD8
T cells and traffics MHC-I molecules to endocytosed antigen from a cellular source other than the ERC. Using a
variety of validated and complementary approaches, we will investigate TLR-regulated mechanisms of endocytic
antigen cross-presentation and subcellular MHC-I trafficking to endocytosed antigens. We will elucidate how the
distinct TLR mechanisms that regulate endocytic antigen cross-presentation impact protective circulating and
tissue-resident CD8 T cell memory elicited by vaccination. We will use prototype subunit vaccines formulated
with adjuvant/TLR ligand combinations that engage and boost DC endocytic antigen cross-presentation.
Deciphering regulatory mechanisms of endocytic antigen cross-presentation will directly impact the design of
effective CD8 T cell vaccines to clinically relevant old and new pathogens including those with pandemic potential.

Public health relevance
PROJECT NARRATIVE The studies we propose here should lead to the development of urgently needed vaccines that overcome the barriers for successful mobilization of CD8 T cell responses against clinically important intracellular pathogens such as HIV, Ebola, and Dengue viruses for which no vaccines are currently available. Dissecting the subcellular mechanisms that optimize microbial antigen cross-presentation during infection will inform the design of effective CD8 T cell vaccines.